Deciphering Mechanisms of Stress and Immune Signaling Driven by mRNA Decay

PROJECT SUMMARY/ABSTRACT
The mammalian immune system is critically dependent on the activity of two sister receptors, RNase L
and Ire1, which provide innate immune defense against viral double-stranded RNA, and ensure production of
secreted proteins such as antibodies and mucins. Recent work reveals that these two receptors employ a
unique strategy not used by any other signaling proteins: cleavage of messenger RNA (mRNA). The goal of
the proposed work is to decipher the cellular mechanisms of mRNA regulation by RNase L and Ire1 in human
lung epithelial cells. These cells are ideally matched to the biological questions under study due to their high
protein secretion and innate immune activity, as well as strong activity of both RNase L and Ire1. The central
method that will be used and further developed in the proposed work is a new RNA-seq-based protocol,
LRtcB-seq, which allows for RNase L and Ire1 cleavage sites in mRNA to be specifically captured and mapped
with single-nucleotide resolution.
It was recently demonstrated that RNase L uses global mRNA cleavage to reprogram translation, in a
mechanism that favors innate immune protein synthesis. Preliminary data now suggest there is an additional
layer to this mechanism; ribosomes become stalled on abundant 2’,3’-cyclic phosphate ends in mRNA
produced by RNase L activity. It is further posited that ribosome stalling contributes to the rapid translational
arrest enacted by RNase L, which is then corrected by the key ribosome rescue factor Pelota to enable
immune defense protein synthesis. Aim 1 of this proposal focuses on interrogating ribosome stalling by cyclic
phosphates using LRtcB-seq, and to determine the role of Pelota in resolving ribosome stalls and promoting
innate immune defense. Although RNase L and Ire1 function in separate pathways, growing evidence indicates
Ire1 too can execute broad mRNA cleavage to modulate cell function. This process, termed regulated Ire1-
dependent decay (RIDD), is the least defined activity of Ire1, particularly for human cells. Aim 2 of this proposal
addresses the key question in the RIDD field: which mRNAs, cell-wide, are the direct targets of Ire1. The
proposed LRtcB-seq-based approach is both sensitive and unbiased, overcoming a critical deficiency in
current literature. The comprehensive mapping of mRNA cleavage targets will advance mechanistic
understanding of the cellular functions of RNase L and Ire1, and lay necessary foundations for developing
therapies for infections and protein folding diseases. The proposed work brings together the lab of Alexei
Korennykh (Princeton), who has years of experience in mechanistic and cell biology studies of RNase L, and
the lab of Peter Walter (UCSF), who is a key co-founder of the Ire1 field. The collaboration between these labs
will provide the foundation for achieving the aims of the proposed work and for scientific development of the
trainee.

Public health relevance
PROJECT NARRATIVE The sister receptors RNase L and Ire1 use mRNA cleavage to effect innate (RNase L) and adaptive (Ire1) immunity. The proposed work aims to elucidate how these two proteins employ this unique signaling strategy to drive immune and stress responses in human lung cells. By advancing the molecular understanding of RNase L and Ire1, our work will lay the necessary foundation for targeting these receptors during viral infections and in protein folding diseases.